BCI2000: Software Resource for Adaptive Neurotechnology Research

The central nervous system (CNS) changes throughout life, and its interactions with the world produce activity-
dependent plasticity that enables it to acquire and maintain useful behaviors. Recent scientiﬁc and technical
advances support the development of systems that create novel interactions with the CNS that can induce and
guide beneﬁcial plasticity. These systems, called adaptive neurotechnologies, measure signals from the CNS and
concurrent behavior, derive from those signals the state of the CNS, and adaptively provide real-time feedback
that can restore, replace, enhance, supplement or improve CNS functions impaired by injury or disease. Thus,
they can provide important new therapies for neurological disorders.
The development and use of adaptive neurotechnologies is an inherently multidisciplinary endeavor. The
integration of knowledge and ideas from these diverse areas, and their implementation by highly sophisticated
software/hardware systems, requires substantial time, effort, and multidisciplinary expertise. This slows progress
in research and development of adaptive neurotechnologies and limits the number of groups that are successful in
realizing these technologies. The present proposal seeks to address these two major problems.
Over the past 18 years, we have developed and disseminated a software platform, called BCI2000, that
supports interactions with the CNS and can implement a wide range of adaptive neurotechnologies. To date,
we have provided it to more than 6,000 users worldwide who have used it to support experiments described
in over 1,200 peer-reviewed publications. Despite this demonstrated value, BCI2000 adoption is limited by the
requirements of substantial programming expertise and in-depth understanding of BCI2000 concepts needed to
adapt and integrate BCI2000 into the speciﬁc experimental protocols and hardware technologies of a particular
laboratory. Thus, most research groups cannot take advantage of the advantages provided by BCI2000. We
propose to address this deﬁciency by simplifying the task of conﬁguring BCI2000 for all major classes of adaptive
neurotechnology experiments (Aim 1), and by providing a succinct introductory course and on-site training for
scientists, engineers, and clinicians (Aim 2). We hypothesize that this work will greatly accelerate realization of
adaptive neurotechnologies that will reduce the devastating impact of neurological disorders.
Achieving these two aims will create and disseminate a major new software resource for adaptive neurotechnol-
ogy research. Its unique utility should enable more scientists, engineers, and clinicians to engage in this exciting
work. Furthermore, this common, interoperable, readily adopted, and easily adapted platform should foster a
collaborative environment that enables diverse investigators to work together and complement each other. In sum,
we expect that the work of this proposal will accelerate realization of novel adaptive neurotechnologies that will
hasten scientiﬁc investigations to improve treatment for many devastating neurological disorders.

Public health relevance
Adaptive neurotechnologies interact with the nervous system to provide new therapies for a wide variety of neurological disorders. The development of these technologies is complex, time-consuming, and costly. In this project, we propose to provide and to widely disseminate a software resource that greatly simpliﬁes the development process, and thereby accelerates the realization of new adaptive neurotechnologies that will improve diagnosis and treatment of many devastating neurological disorders.